Mechanistic Modeling of Cellular Systems

Abstract This is an equipment supplement application for the National Resource for Mechanistic Modeling of Cellular Systems to purchase a Qumulo active archive class hybrid storage cluster with a 1 PB raw capacity to provide for redundant/backup storage of users simulation results. The compute infrastructure includes backup capabilities only for user models and not for simulation results. In the event of a loss of simulation results data, recreating the data by re- simulating models can be very costly and lead to many months of data unavailability. The proposed cluster would be operated and maintained by the UConn Health High Performance Facility staff and housed at a remote data center location for disaster recovery purposes.

Public health relevance
Project Narrative Computational modeling, enabled by COPASI and VCell technologies, will offer deep insights into mechanisms by which cells function and the cellular basis of disease. Projects by our user base focused on cancer, neurological disorders, diabetes, kidney disease, cardiology and aging, for example, all utilize mathematical models developed with the aid of VCell and COPASI.